Applying Innovative Lung Mapping Strategies to Understand Alveolar Capillary Barrier Permeability in ARDS

Project Summary
This R35 application describes a robust research framework to facilitate discovery and translation of new
therapeutic targets in Acute Respiratory Distress Syndrome (ARDS), a common cause of acute respiratory
failure that carries a high mortality rate and has no beneficial targeted therapies. ARDS remains a significant
health problem affecting 190,000 Americans per year, costing billions of dollars, and leaving the majority of
patients dead or significantly impaired. New insights into the pathogenesis are needed to deepen our
understanding of the underlying mechanisms that lead to ARDS as well as to develop novel therapeutics.
Thus, there is an unmet need to define clinically relevant therapeutic targets that can be studied
mechanistically and rapidly carried through robust pre-clinical studies. For the last 14 years I have been
building my research team to be on the forefront of translational discovery. My group has made major
contributions to understanding ARDS pathophysiology. The major focus of my laboratory is defining the key
cellular and molecular regulators of alveolar capillary barrier function and dysfunction that underlies ARDS
pathology. My R35 research program is designed to identify novel mediators in ARDS using lung tissue
imaging mass spectrometry and deep phenotyping of gene expression profiles at the single cell level coupled
with advanced statistical methods to identify leading targets. New targets will be studied in in vitro transgenic
model systems to define cellular and molecular mechanisms in order to facilitate the development of novel
therapeutics to be tested in pre-clinical models. My research framework is centered on three goals: Discovery,
Mechanism and Translation. Goal 1 – Discovery. To accomplish this goal, we will break new ground using
imaging mass spectrometry and single cell RNA sequencing to create an expression profile and protein “map”
of the injured and uninjured human lung. Using advanced statistical approaches, we will identify promising
targets to take forward into further studies. Goal 2 – Mechanism. Leveraging our existing lung injury models,
institutional resources and new approaches, we will define the fundamental pathologic mechanisms that lead
to alveolar capillary barrier permeability in ARDS by generating novel transgenic cell and mouse lines for
mechanistic studies. Goal 3 – Translation. Building on our existing ex vivo human lung and in vivo mouse
models, we will generate rigorous pre-clinical data based on new targets identified in our Discovery and
Mechanism studies. With this R35, my lab will advance the mission of the NHLBI by: generating a catalogue of
single cell transcription profiles and tissue protein expression levels in acutely injured and uninjured human
lung, identifying novel therapeutic targets in ARDS, defining the cellular and molecular mechanisms regulating
alveolar capillary barrier dysfunction and conducting pre-clinical studies in mouse and human models. The R35
will provide the support and flexibility necessary for me to break new ground in ARDS.

Public health relevance
Narrative Acute respiratory distress syndrome (ARDS) is a common and life-threatening condition that is most frequently caused by sepsis, has a 30-50% death rate, and has no disease-specific therapies. The goal of my research program is to develop a discovery and mechanistic pipeline to identify clinically relevant mediators of ARDS, and rapidly translate the most promising findings into pre-clinical models. Using our novel discovery methods, model systems and translational research approach, we will transform our understanding of ARDS pathogenesis and lay the groundwork for future clinical trials.